Sex/Drug Tourism at the US/Mexico Border: Social Network Influences on HIV Risk.

DESCRIPTION (provided by applicant): The purpose of this Mentored Research Scientist Development Award (K01) is threefold. This award will allow me to: 1) learn a new skill set (social network analysis; SNA), 2) broaden my understanding of the social epidemiology of HIV among drug users in a new cultural and environmental context (the US/Mexico border), and 3) facilitate my transition to becoming a productive NIH-funded independent investigator at the University of California San Diego. The training aims will be accomplished through a combination of specific workshops and coursework, a hands-on practicum, and one-on-one mentoring with a Training Committee comprised of experts in the areas of HIV prevention research among vulnerable populations, behavioral intervention design, social network analysis, and HIV social epidemiology research in international contexts (and specifically the US/Mexico border region). The research aims will be accomplished by conducting a cross-sectional study of the social network factors associated with HIV risk behavior among 200 drug-using male clients of female sex workers (FSWs) in Tijuana, Mexico. The US/Mexico border is experiencing a burgeoning HIV epidemic, concentrated among high-risk groups such as drug users and FSWs. Social network analysis (SNA) has been used for many years in the US to understand the role of drug user social networks in regional HIV transmission, but rarely has it been used between regions or across international borders, which are characterized by high levels of cross-border mobility. Understanding the role of social networks in highly mobile bridging populations is critical to a more nuanced and contextualized understanding of infectious disease transmission in border regions. The proposed research will allow me to apply newly acquired skills in SNA to evaluate the structure, composition, and influence of social networks, and the degree of interaction among drug, sex, and social networks of a particularly high-risk group: US and Tijuana-based drug-using male clients of FSWs. This population exhibits high rates of drug use (25% report ever injecting drugs, and up to 88% report lifetime use of cocaine, heroin, or methamphetamine) and considerable sexual risk behavior with both FSWs and other partners (including 66% who report concurrent sex and drug use). Findings from the proposed research will be critical for developing tailored interventions for individuals at risk for HIV via sex and drug use in border regions, and for the development of future research into the mobility-HIV risk pathway. Further, developing skills in social network analysis will uniquely position me as one of only a handful of mixed-methods researchers in the field of drug abuse possessing such skills, and the only one in the Division of Global Public Health at the University of California San Diego.

Public health relevance
PUBLIC HEALTH RELEVANCE: The US/Mexico border is home to an evolving HIV epidemic among vulnerable groups such as drug users, including female sex workers (FSWs) and their clients, but little social epidemiological research has assessed the role of social networks in influencing transmission of HIV in this region. Findings from the proposed research will be critical to bi-national efforts to develop tailored interventions for drug users at risk for HIV, and for the development of future long-term research into the influence of social networks on HIV risk among mobile "bridging" populations who have the potential to connect higher- and lower-risk groups. Further, developing skills in social network analysis will uniquely position the candidate as one of only a handful of mixed-methods researchers in the field of drug abuse possessing such skills, and the only one in the Division of Global Public Health at the University of California San Diego. Project Narrative The US/Mexico border is home to an evolving HIV epidemic among vulnerable groups such as drug users, including female sex workers (FSWs) and their clients, but little social epidemiological research has assessed the role of social networks in influencing transmission of HIV in this region. Findings from the proposed research will be critical to bi-national efforts to develop tailored interventions for drug users at risk for HIV, and for the development of future long-term research into the influence of social networks on HIV risk among mobile "bridging" populations who have the potential to connect higher- and lower-risk groups. Further, developing skills in social network analysis will uniquely position the candidate as one of only a handful of mixed-methods researchers in the field of drug abuse possessing such skills, and the only one in the Division of Global Public Health at the University of California San Diego. __SpecificAimsTextDelimiter__ 10. Specific Aims International borders represent a unique "risk environment"1 where policy, geography, culture, social networks and norms, and disease interact to contribute to HIV risk. The US/Mexico border region is experiencing a burgeoning HIV epidemic among drug users and other vulnerable populations.2 The goal of the proposed project is to identify the role of social network factors in influencing HIV risk behaviors in the context of the US/Mexico border, specifically among high-risk drug users residing in San Diego, CA and Tijuana, Mexico. Differences in culture, physical environment, drug policy (possession of small amounts of drugs for personal use was decriminalized by Mexican law in 2009), and HIV seroprevalence between the US and Mexico make an understanding of the social ecology of HIV risk critical to bi-national efforts to implement interventions to stem the growing HIV epidemic among drug users in this region. Individuals living on the US/Mexico border form a largely contiguous population, characterized by considerable cross-border mobility. Mobile individuals engaging in HIV risk behaviors can serve as a "bridge" between high-and low-risk groups,3 both between and within countries, which can increase HIV risk in existing social networks. Social Ecological models4, 5 incorporate features of the individual, social and physical environment, and can be used to understand how intermediary factors interact to shape HIV risk. The social environment, including both social network structure and social norms, is a key component in the ecology of HIV risk and one of the potential mechanisms through which cross-border network interactions could affect HIV risk. Social network analysis (SNA) has been used for many years in the US to understand the role of drug user social networks in HIV transmission,6-12 but rarely has it been used between regions or across international borders. Understanding the role of social networks in bi-national populations is critical to a more nuanced and contextualized understanding of infectious disease transmission in border regions.13 The proposed research will use SNA to describe the characteristics, influence, and interaction of drug user social networks to understand HIV risk dynamics in a particularly high-risk group: US- and Tijuana-based drug- using male clients of female sex workers (FSWs). This population is highly mobile, exhibits high rates of drug use (25% report ever injecting drugs, up to 88% report lifetime use of cocaine, heroin, or methamphetamine)14 and considerable sexual risk behavior with both FSWs and other partners (including concurrent sex and drug use), making them a potential "bridge" for HIV transmission. The characteristics of this population, combined with the unique features of the international border, make the region an ideal "natural laboratory" for understanding the role of social networks in influencing HIV risk among bi-national populations. The proposed study will address the following specific aims and research questions: 1. To describe the social, drug and sexual networks of drug-using male clients of FSWs residing in San Diego, California and Tijuana, Mexico Q1: What are the structural characteristics of male clients' networks? (e.g., size, multiplexity, assortativity)? Q2: What are the behavioral characteristics of male clients' networks in terms of drug and sexual risk behavior and cross-border mobility? Q3: What is the composition of male clients' networks in terms of sex, country of origin, ethnicity, %IDU, %FSW, %HIV+ Q4: How much interaction (or overlap) is there between networks reported by men residing in San Diego and Tijuana? 2. To assess the association between network characteristics (e.g., structure, behavior, composition, interaction) and HIV risk behavior among drug-using male clients of FSWs residing in San Diego and Tijuana Q1: What social network factors are associated with drug risk behavior? Q2: What social network factors are associated with sexual risk behavior? Q3: Do social norms mediate the association between social network factors and HIV risk behavior? 3. To compare the structure, composition, and influence of networks described by drug-using male clients residing in San Diego to those residing in Tijuana. To address these aims we will conduct a cross-sectional social network study with 200 male clients of FSWs in Tijuana. Though all will be recruited in Tijuana, half of the sample will be San Diego residents and half will be Tijuana residents, allowing for comparisons between San Diego and Tijuana networks. Findings from the proposed research will be critical for developing tailored interventions for drug users in border regions, and for the development of future research into the mobility-HIV risk pathway. Developing skills in SNA will uniquely position the candidate as one of only a handful of mixed-methods drug abuse researchers possessing such skills, and the only one at UCSD.!